Biologic Mechanisms of Labor Dysfunction: A Systems Biology Approach

Project Abstract
Maternal mortality in the US continues to rise, outpacing rates in nearly every other developed country. Over
half of women who experience pregnancy-related death do not have risk factors that are identifiable prior to
labor. For these women, the cascade of events ending in death or morbidity often begins with labor
dysfunction. Current literature on the physiologic determinants of labor dysfunction suggests that lipotoxicity
may account for decreased uterine contractile strength and coordination. Lipotoxicity is a system-wide
condition occurring when excess free fatty acids are deposited in cellular membranes and non-adipose tissues,
causing chronic inflammation and cellular dysfunction in both obese and non-obese women. Black women are
3-4 times more likely to die of pregnancy complications than non-Hispanic white women, and social
determinants of health appear to increase their risk of experiencing changes in metabolism during pregnancy.
We theorize that alterations in lipid profiles may provide a missing link connecting Black women's pregnancy
experiences, health, and labor outcomes. The proposed study will use a systems biology approach to
determine how the lipid changes that precede labor dysfunction develop over the course of pregnancy in a
cohort of Black women receiving prenatal care in a freestanding birth center (Aim1), and measure the extent to
which these lipid changes are influenced by pregnancy health, including maternal behaviors, body
composition, social determinants of health, and serum adipose tissue hormones (Aim 2). Finally, we will
evaluate the influence of prenatal model of care on pregnancy health and lipid perturbations during pregnancy,
comparing the birth center cohort to a cohort of Black women receiving prenatal care in a hospital setting (Aim
3). Recruitment of the birth center cohort will target retention of 150 women who begin prenatal care in first
trimester for planned questionnaire and blood collections. Following the completion of labor, detailed chart-
review will be performed to identify cases and comparisons for labor dysfunction comparisons. For our final
analyses examining the influence of prenatal model of care on lipids and labor outcomes, we will leverage
questionnaire and lipidomics data from an existing cohort of 167 Black women with similar levels of perinatal
risk to the birth center cohort who received prenatal care in nearby hospital clinics. Differential analysis will
then be used to compare lipid features and pregnancy exposures between groups. The proposed research
study brings together cutting-edge technology and a multi-disciplinary team with scientific expertise in labor
dysfunction, body composition measurement, comprehensive nutritional and physical activity analysis,
lipidomics, racial disparities investigations, and systems biology approaches to confront labor dysfunction--one
of the most impactful conditions affecting maternal morbidity and mortality. Results obtained from this study will
provide functional information to make the identification of biomarkers that predict labor dysfunction a real
possibility, changing the future for early detection, targeted intervention, and prevention of labor dysfunction.

Public health relevance
Project Narrative Difficulties of labor initiation and progression are responsible for much of the injury and death seen around the time of birth in both women and their neonates, and Black women are much more likely than white women to experience injury and death around the time of birth. The proposed project will measure social determinants of health, pregnancy lifestyle, and blood samples in two groups of Black women who receive prenatal care in either a freestanding birth center or a hospital clinic to better understand how pregnancy experiences and health influence labor outcomes. The purpose of this project is to promote health and eliminate health disparities through a better understanding of the physiology of labor dysfunction.